Photodynamic therapy with prior inhibition of epidermal growth factor receptor to stimulate antitumor innate immune response

Inhibition of epidermal growth factor receptor (EGFR) prior to the delivery of photodynamic therapy (PDT) can remarkably improve treatment efficacy in animal models of non-small cell lung cancer (NSCLC). Currently, clinical use of EGFR tyrosine kinase inhibitors (TKIs) for treatment of patients with NSCLC is limited to those with EGFR mutated disease. EGFR-TKI therapy is typically continued until time of disease progression since most patients eventually develop EGFR-TKI resistant disease. Here, we propose to use EGFR-TKIs as a brief, priming therapy for several days rather than as a daily continuous therapeutic. Importantly, as a priming therapy, we hypothesize that EGFR-TKI pretreatment will improve the therapeutic efficacy of PDT (and ionizing radiotherapy, XRT) through an innate immune response-dependent mechanism. Significantly, we posit that the use of EGFR-TKIs as a priming approach to stimulate innate immunity is relevant to patients with EGFR wild-type disease. However, its potential efficacy may not be apparent in the setting of daily continuous EGFR-TKI therapy due to suppression of innate and adaptive immunity by prolonged use of EGFR-TKIs. As a priming therapy, EGFR-TKIs could augment responses to PDT and XRT through multiple mechanisms that involve cooperation between the EGFR-TKIs and PDT or XRT to promote tumor-directed innate immunity. EGFR-TKIs may increase neutrophil activation in tumors receiving PDT or XRT, serving to increase vascular damage and/or stimulate other cells of the innate immune system, such as innate immune lymphocytes. Indeed, our published data show EGFR-TKI to increase vascular damage to PDT, and preliminary data demonstrate increases in tumor-localized neutrophil activation when PDT is preceded by EGFR-TKI (EGFR- TKI/PDT). Additionally, EGFR-TKIs and PDT or XRT may cooperatively increase numbers of innate immune lymphocytes and the immunologic visibility of target cells (e.g., tumor cells or tumor-associated endothelial cells) to these lymphocytes. In fact, in preliminary data the efficacy of EGFR-TKI/PDT is dependent on the innate immune lymphocytes NK and ?? T cells. We note that the role of ?? T cells in response to EGFR-TKI, notwithstanding combinations with PDT or XRT, is a novel area of investigation. Moreover, we uniquely investigate EGFR-TKI priming with proton XRT. Knowledge gained from this proposal will guide selection of a clinical approach to EGFR-TKI priming with radiation therapy, whether it be with PDT, photon XRT, or proton XRT. Toward this goal, we will address the following aims: Aim 1. To define the role of neutrophils in promoting vascular damage when PDT is preceded by EGFR-TKI. Aim 2. To ascertain how pretreatment with EGFR-TKI augments the response of innate immune lymphocytes to PDT-treated tumors. Aim 3. To establish the efficacy and innate immune effects of EGFR-TKIs combined with ionizing radiation therapies (photon and proton) and demonstrate application in control of lung metastasis.

Public health relevance
Non-small cell lung cancer (NSCLC) makes up over 80% of new lung cancer cases in patients, the majority of whom present with advanced stage disease and for whom standard frontline treatment will include tyrosine kinase inhibitors (TKI) of epidermal growth factor receptor (EGFR) if their disease contains EGFR sensitizing mutations. EGFR-TKI therapy is typically continued until time of disease progression since most patients eventually develop EGFR-TKI resistant disease, but here we propose to use EGFR-TKI as a brief, priming therapy for several days prior to photodynamic therapy (PDT) or ionizing radiation (XRT) in order to augment innate immune response to PDT (and XRT) in a manner that is applicable to patients with either wild-type or mutant EGFR expressing cancers. Toward these goals, we propose that it is important for EGFR-TKI to be delivered as a priming therapy because prolonged use can abrogate immunity; thus both the biological mechanisms and intended clinical application of our proposed approach serve to distinguish it from prior research.